Morphological Determinants of Intracellular Membrane Compartments

Project Summary/Abstract

Eukaryotic cells organize their interior into a set of membrane-­enclosed compartments, referred to as organelles
or the endomembrane system, that enable cell growth and viability. Each organelle exhibits a unique biochemical
composition, complex dynamics, and a distinct morphology. How organelles are shaped, how their shape is
linked to their functions, and how individual organelles engage in specific contacts are important open questions
that are the focus of the proposed research.
Understanding of the spatial organization of human cells is currently experiencing a revolution, with the
realization that components of the cytoplasm can undergo a “liquid-­liquid” phase separation from the rest of the
cytoplasm, forming dynamic and functionally specialized domains that lack any membrane. Our recent research
raises the novel possibility that membrane-­containing organelles are structured by a two-­dimensional variation
of this principle, in which ‘rod-­like’ proteins (‘golgins’ and golgin-­like proteins) self-­assemble into lamellar liquid
geometries. We aim to test and develop this new organizing principle in context of the organization of the early
secretory pathway, where two organelles, the ER and the Golgi stack, form a ‘synapse-­like’ interface that is
conserved across taxa. It is poorly understood how the spatial organization of the ER-­Golgi interface is achieved,
and why this specific organization is required. It is also a mystery how this junction can exhibit structural integrity
while resisting a high throughput of material, yet exhibit dynamic properties under specific regulatory cues.
Our goal is to understand the mechanisms that establish the specific morphology of the ER-­Golgi interface in
order to enable efficient processing and sorting of cargo within this space. Our motivating hypothesis is that this
interface represents a dynamic membrane contact site organized by local phase separation proteins. We will
employ a ‘bottom-­up’ approach in which we purify individual components to homogeneity and probe them in a
model membrane environment, seeking out the minimal components and mechanisms needed to reconstitute
morphology and function. We will complement this approach with super-­resolution and electron microscopy,
genetic perturbations and functional assays in both human cell lines and in the model organism C. elegans.
Through this dual strategy, we expect to elucidate the principles by which the ER-­Golgi interface is formed,
maintained, and how its spatial organization impacts cellullar functions.

Public health relevance
Project Narrative The interior of a human cell is organized through a series of chemically and morphologically distinct membrane- enclosed compartments, the organelles. The proposed research aims to address how these compartments are structured, and how they interact. Understanding the basic mechanisms that govern intracellular organization is critical to our understanding of tissue cell function and lays the foundation to address disease phenotypes that coincide with a loss of organization, such as in neurodegeneration and carcinogenesis.